Evaluating the effects of preschool access policies on parents' cardiovascular health and health inequities: a quasi-experimental population-based investigation

PROJECT SUMMARY
For the approximately 28 million parents of young children in the US, the demands of parenthood can increase
well-known risk factors for cardiovascular (CV) disease. The US has the highest childcare costs relative to
parents’ wages in the world, one of the lowest preschool attendance rates among high-income countries, and
large inequities in access to preschool by sociodemographic factors. The financial and time pressures of
childcare may increase stress and prevent parents from participating in physical activity, accessing healthy
foods, and getting enough sleep–especially for parents with fewer resources. To support young families, some
states have enacted policies for universal pre-kindergarten (pre-K) access for 3- and 4-year-old children.
Universal pre-K may help parents maintain CV health, however, the limited research in this area has focused
on occupational outcomes for parents and no research has evaluated the impact of universal pre-K on parent
health. The proposed research will leverage the National Health Interview Survey (NHIS) to contribute
evidence on the relationships between parenthood, universal pre-K, and sociodemographic factors in
influencing parents’ CV risk factors. The study will examine five CV risk factors for parents: physical activity,
sleep, body mass index (BMI), smoking, and alcohol use. Aim 1 will build on existing evidence on associations
between parenthood and CV risk factors by examining whether sociodemographic factors modify these
associations and evaluating secular trends over time. Insights will help identify at-risk subgroups for tailoring
prevention efforts and addressing existing inequities in CV health. Aim 2 will examine the impact of universal
pre-K on parent CV risk factors, leveraging multiple sources of quasi-random policy variation. The candidate
will create a novel database of geographic and temporal variation in universal pre-K and co-occurring policies
to link the policy environment a parent is exposed to (based on their childrens’ year of birth and state of
residence) to NHIS. Aim 3 will determine whether the impact of universal pre-K on parents’ CV risk factors
varies by sociodemographic factors. Aims 2 and 3 will contribute robust quasi-experimental evidence to inform
policymaking. This study will contribute the first examination of the potential effectiveness of universal pre-K as
a population-based strategy to improve CV risk factors for parents and reduce later-life development of CV
disease. This research will support NHLBI’s objective to investigate factors that contribute to cardiovascular
health inequities and identify strategies to mitigate inequities on a population-level. Supported by a team of
expert mentors, the candidate will benefit from coursework, directed mentorship, and a world-class research
training environment at the University of California, San Francisco. The candidate will receive training in the
etiology of CV risk factors, advanced methods for policy evaluation in the presence of co-occurring policies,
and optimizing research for informing policymaking. This fellowship will prepare the candidate for a future
career as a social epidemiologist examining the health impacts of complex social policies.

Public health relevance
PROJECT NARRATIVE Universal pre-kindergarten (pre-K) represents a potential population-based strategy for improving parents’ cardiovascular (CV) health by alleviating financial and time pressures of childcare and enabling participation in healthy behaviors. The proposed study will address the lack of research on the impact of universal pre-K on parent health and the relationships between parenthood, universal pre-K, and sociodemographic factors in influencing parents’ CV risk factors. This project will contribute the first evidence on the potential effectiveness of state-level universal pre-K policies to improve CV risk factors for parents and address inequities in CV health for particularly at-risk subgroups of parents.